Immunobiology and Physiology of Liver xenograft in the Decedent

Abstract
Recent advances in genetic engineering have enabled significant modifications in porcine organs, such as the
removal of glycan sequences linked to hyperacute rejection, inactivation of porcine endogenous retroviruses,
and expression of human proteins to mitigate inflammation and immune responses. Transplantation of
genetically modified pig kidneys and hearts into non-human primates (NHPs) and limited human studies have
demonstrated physiological function with tailored immunosuppression. However, liver xenotransplantation in
NHPs faces physiological and immunological challenges, including severe thrombocytopenia, metabolic
incompatibilities, and the need for a deeper understanding of the immune response to liver xenografts.
We propose using human brain-dead donors (decedents) to investigate liver xenograft physiology and early
immune responses. Our decedent model employs an extracorporeal liver cross-circulation system, where the
liver xenograft is connected to the decedent via venous bypass lines, allowing systemic circulation and
observation of interactions between the liver xenograft and human physiology. This model facilitates monitoring
xenograft function and collecting specimens for studying immune responses, hematological dysregulations, and
metabolic functions. We hypothesize that decedent studies can accurately replicate the early post-transplant
experience in humans, thereby identifying uniquely human immune, metabolic, and pharmacological responses.
Aim 1 focuses on defining early innate and adaptive immune responses to genetically modified liver
xenografts. Advanced technologies, including spatial transcriptomics and single-nucleus RNA sequencing, will
generate comprehensive datasets to identify biomarkers of xenoimmune responses. Cell type specific cell-free
DNA studies will enhance the monitoring of immune cell activation and liver xenograft injury, providing qualitative
and quantitative insights into adaptive xenoimmune responses.
Aim 2 is designed to elucidate physiological compatibilities in liver xenotransplantation and evaluate
therapeutic interventions. First, we will assess liver xenografts' metabolic and detoxification functions using non-
radioactive tracers and metabolomic assays to profile phenotypes that may be associated with xenograft
dysfunction, impact decedent metabolic derangements, and affect xenoimmune response. Second, we will
rigorously test our hypotheses that thrombocytopenia in xenotransplant recipients is driven by either antibody-
mediated platelet phagocytosis, complement-mediated platelet lysis, platelet apoptosis, or porcine molecules
inducing platelet agglutination and activation. These mechanisms for the thrombocytopenia will be analyzed ex
vivo, while their reversibility will be tested in vivo using clinically approved therapeutics.
The study outcomes in a human decedent model are expected to provide insights into early xenograft immune
activation, peripheral biomarkers of xenoimmune response, metabolic compatibility, and potential
pharmacological solutions for hematological dysregulations.

Public health relevance
Narrative The study aims to explore outcomes of genetically modified porcine liver xenograft in human decedent. The outcomes are expected to provide insights into early immune activation, peripheral biomarkers of xenoimmune response, metabolic compatibility, and potential pharmacological solutions for hematological dysregulations.